Horizontal gene transfer as the source of evolutionary innovation in eukaryotes

This is a supplemental equipment request to the project R01GM111917 in response to NOT-GM-22-017
to purchase an ultra-low temperature freezer to store biological samples needed for the project,
including the accumulated biomass, fractionated proteins, RNA, and high-efficiency competent cells. The
samples are currently stored in an outdated communal freezer, which has trouble maintaining the
required temperature and recently had to undergo urgent repairs.

Public health relevance
With this supplemental request, we are seeking to purchase an ultra-low temperature freezer which is critical for storage of biological samples generated in the course of the present project.